Asymmetric synthesis of DNA-encoded libraries of natural product-like compounds.

Project Summary
DNA-encoded library (DEL) technology is a powerful method for the discovery of protein ligands. It is capable
of screening millions of small molecules for a fraction of the price required to conduct traditional, function-based
high-throughput screens. A current limitation of the technology is that it is difficult to incorporate large numbers
of sp3 chiral centers into libraries, since few, if any, asymmetric synthesis methods have been validated for DEL
synthesis. This is unfortunate, since there is general agreement that DELs with more natural product-like
characteristics would be a highly valuable source of drug leads. Here we will adapt asymmetric organocatalytic
aldol reactions for solid-phase synthesis of DELs. This effort will involve the development of a novel proximity
catalysis method to drive otherwise recalcitrant reactions. If successful, this work will enable the synthesis of
DELs of unprecedented stereochemical complexity.

Public health relevance
Project Narrative There is great interest in the construction of screening collections with more natural product-like characteristics, especially the presence of multiple chiral sp3 centers. We will develop a method that will allow us to use multiple asymmetric aldol reactions to construct DNA-encoded libraries (DELs) of natural product-like macrocycles with multiple chiral centers.